New methods for studying thousands of complete human and vertebrate genomes

PROJECT SUMMARY / ABSTRACT
We propose to advance comparative genomics through three interconnected aims.
In Aim 1, we will scale genome alignment and analysis capabilities to accommodate the rapidly growing
number of available vertebrate genomes, projected to reach ~10,000 species within four years. We propose
developing a highly scalable, automated pipeline for species-tree construction from raw genome assemblies,
reworking the genome-based HAL format, and introducing a new column-based alignment format (TAF) to
facilitate efficient representation and analysis of large-scale alignments. To demonstrate these improvements,
we will create and share the deepest ever vertebrate alignments, focusing on predictions of evolutionary
selection.
In Aim 2, we address the challenge of aligning telomere-to-telomere (T2T) human genome assemblies. We will
develop novel repeat-aware alignment algorithms and graph models to enable a more complete alignment,
starting with human centromeres and extending to other heterochromatic sequence. We will integrate these
methods into our pangenome construction process to facilitate T2T alignment within the human pangenome.
Aim 3 focuses on disentangling the genetics of the 1q21.1 region, which is associated with various
neurodevelopmental disorders, as an exemplar of a difficult segmental duplication. We will analyze T2T ape
and human genomes to create a comprehensive 1q21 pangenome, develop efficient methods for
high-resolution genome reconstruction of patient-derived cell lines with 1q21.1 copy number variations, and
test the functional consequences of identified genetic alterations using hiPSC-derived cerebral cortex
organoids. By combining advanced genomic analysis, efficient sequencing protocols, and functional studies,
we aim to significantly advance our understanding of genome evolution, improve our ability to analyze complex
genomic regions, and potentially lead to improved diagnostics and therapeutic strategies for
neurodevelopmental disorders associated with the 1q21.1 region.
Together, these advancements will empower the community to conduct more comprehensive comparative
genomic analyses, leading to a deeper understanding of genome evolution across vertebrates and humans
and its implications for human health.

Public health relevance
PROJECT NARRATIVE To capitalize on the growth and increasing quality of available vertebrate and human genomes, we envisage the community building and sharing a combined evolutionary history of all vertebrate genomes including numerous human assemblies combined in a pangenome. We will create software capable of computing a draft-phylogeny and alignment at the scale of 10,000 vertebrate genomes, capitalize on the opportunities presented by telomere-to-telomere (T2T) human genome assemblies to understand the sequence evolution of previously missing sequences, such as centromeres, and disentangle the genomics of the 1q21 segmental duplication hub.